Transcriptional control of growth plate chondrocytes

PROJECT SUMMARY
Growth plates are highly specialized cartilage structures that ensure skeletal growth and endochondral
ossification during fetal and postnatal development. They are formed and maintained by chondrocytes, as
these cells follow a spatially and temporally tightly controlled multi-step differentiation program. The present
project focuses on transcription factors that have pivotal roles in effecting this program, but whose modes of
actions remain incompletely deciphered. It will test the paradigm-shifting hypothesis that SOX9, its cofactors
SOX5 and SOX6, and RUNX2 and RUNX3 fulfill many of their main functions in a cooperative manner. This
hypothesis is based on a solid scientific premise that includes co-expression of the factors in growth plate
chondrocytes, the presence of RUNT-domain motifs in many chondrocyte-specific enhancers bound by SOX9,
and preliminary evidence that the SOX and RUNX proteins have synergistic activities in enhancer activation.
Specific Aim 1 is to determine whether SOX5/6, SOX9 and RUNX2/3 genetically interact during growth plate
formation in mouse fetuses and in the maintenance of active growth plates in juvenile mice. Specific Aim 2 is to
profile the whole genetic targetomes of SOX5/6, SOX9 and RUNX2/3 in growth plate chondrocytes, and to
assess and validate their overlap. Specific Aim 3 is to identify mechanisms underlying SOX5/6, SOX9 and
RUNX2/3 cooperativity. The proteins will be tested for roles in inducing chromatin accessibility and three-
dimensional connectivity, and for cooperativity in DNA binding and recruitment of functional partners. New
findings should have a significant impact on current understanding of fundamental mechanisms governing the
formation and maintenance of growth plates and other cartilage types. They should thereby help uncover the
molecular basis of many types of pathologies, including chondrodysplasias, tumors and joint degenerative
diseases, and also suggest novel, innovative and efficient treatments for these still unsatisfactorily treatable
diseases.

Public health relevance
PROJECT NARRATIVE Skeletal growth is achieved as growth plate chondrocytes follow a tightly controlled multi-step differentiation process. This project will test the hypothesis that the transcription factors SOX5/6, SOX9 and RUNX2/3 fulfill many of their key functions in these cells in a highly cooperative manner. Verification of this paradigm-shifting hypothesis should deepen understanding of the genetic mechanisms driving skeletogenesis, help uncover the molecular basis of various types of skeletal dysplasias, cartilage tumors and joint degeneration diseases, and illuminate new strategies to prevent and treat these diseases.